Genome Engineering Core

GENOME ENGINEERING CORE - ABSTRACT
The goal of the Genome Engineering Core (GEC) of the Washington University Rheumatic Diseases Research
Resource-based Center (WU-RDRRC) is to provide access to innovative genomic technologies to build tools
that will facilitate pre-clinical modeling and functional testing for the investigation of inflammatory and
autoimmune disease. Genomic investigation of the basis of rheumatic disease has become widespread.
However, the translation of genetic findings can be challenging, requiring development of models to interrogate
basic questions of cellular and disease phenotype and function due to identified genetic changes. This requires
development of validated models through innovative genome engineering technologies. These technologies,
such as development of genetically-engineered mice and CRISPR/Cas9 editing of induced pluripotent stem cells
(iPSCs) and mouse embryos require significant experience and highly-specialized equipment not available within
most laboratories. The GEC provides WU-RDRRC investigators with access to the latest in genomic engineering
techniques by leveraging services from the Transgenic and Knockout Mouse Facility (TKMF) and the Genome
Engineering & Stem Cell Center at McDonnell Genome Institute (GESC), with education and leadership to
facilitate projects. We propose to continue these services and innovate the GEC through following three Specific
Aims:
1. Sustain, develop, and introduce new state-of-the-art genetics services to WU-RDRRC members.
2. Assist investigators in the generation of genetically engineered mouse models by partnering with the
Transgenic and Knockout Mouse Facility (TKMF).
3. Assist investigators in the generation of reagents for creation of genetically-engineered cell lines, iPSCs,
and mouse models by leveraging the Genome Engineering & Stem Cell Center at McDonnell Genome
Institute (GESC).